Project 1: Understanding population-based disparities in treatment-associated hepatotoxicity during ALL therapy

Project 1: Understanding population-based disparities in treatment-associated hepatotoxicity during ALL therapy
Project Summary
This proposal seeks to integrate clinical, demographic, lipidomic, and genomic data to advance our
understanding of disparities in treatment-related hepatoxicity (TAH) during induction therapy for pediatric acute
lymphoblastic leukemia (ALL). Improved treatment regimens for pediatric (ALL) have resulted in survival rates
exceeding 90%; however, nearly a quarter of patients experience TAH. Our preliminary evidence identified
striking population-based disparities in the incidence of TAH during the initial induction phase of ALL therapy.
Specifically, Latino patients appear particularly vulnerable to dose-limiting TAH, potentially compromising
treatment efficacy and contributing to well-established disparities in pediatric ALL relapse and survival. This
proposal pursues the central hypothesis that differences in both inherited genetic and modifiable clinical risk
factors contribute to population-based disparities in TAH. Our preliminary data suggests severe TAH can be
reliably predicted using a novel hepatotoxicity risk model, plasma lipid dysregulation is an emerging biomarker
for TAH risk, and murine models of ALL can provide functional insight into the etiology of TAH. Informed by our
preliminary data, the specific research aims of this project will examine: 1) whether consistent and recognizable
alterations in plasma lipid profiles involved in liver function contribute to TAH during pediatric ALL induction
therapy; 2) to what extent consideration of clinical, demographic, genetic, and lipidomic data can inform the
prediction of TAH in heterogenous pediatric ALL populations; and 3) how genetic variation and dyslipidemia
contribute to TAH using a murine model of ALL. This project, which is jointly led by investigators with expertise
in pediatric oncology (Drs. Huynh and Orgel), molecular epidemiology (Dr. Brown) and murine models of ALL
(Dr. Mittelman), builds on the rich resources available in the multi-institutional REDIAL consortium. Leveraging
the Prospective (n=1,369) and U54 Continuation (n=1,000) REDIAL Cohorts, this project will systematically
evaluate risk for severe TAH in newly diagnosed cases of pediatric ALL. Therefore, this innovative proposal will
establish one of the largest prospective investigations of TAH in a cohort of pediatric patients with ALL that is
representative of the Texas and California populations. The comprehensive research plan outlined in this
proposal will address key gaps in our understanding of disparities in the incidence and etiology of TAH and serve
as a unique resource of preliminary data to support future research endeavors. Ultimately, we anticipate that this
line of research will inform risk-stratified approaches to safely deliver curative induction chemotherapy to children
and adolescents treated for ALL to improve their overall survival.

Public health relevance
Project 1: Understanding population-based disparities in treatment-associated hepatotoxicity during ALL therapy Project Narrative The proposed research, which builds upon existing resources to study an adverse consequence of cancer therapy, addresses key gaps in our understanding of treatment-associated hepatoxicity, an adverse event which disproportionally affects Latino patients. This study will combine demographic, clinical, lipidomic, and genomic data, with an emphasis on establishing a novel TAH risk model and identifying modifiable targets to reduce the burden of treatment-related toxicity among the most vulnerable pediatric patients with ALL. This avenue of research has the significant translational potential to inform the delivery of targeted interventions to patients at high risk for TAH, with the ultimate goal of reducing ethnic disparities in ALL treatment outcomes.